(R01) Strengthening the Evidence-Base to Support Medication Prescribing in Older Adults with Chronic Kidney Disease

Chronic kidney disease (CKD) affects 40% of older adults (≥65 years), and is a significant contributor
to morbidity, mortality, and healthcare spending. Although older adults with CKD are more likely to be
diagnosed with multiple chronic conditions, take multi-drug regimens, and owing to pharmaco-
dynamic and -kinetic modulations, are uniquely susceptible to experiencing drug-related harms, they
are routinely excluded from clinical trials. Thus, there is an urgent need to examine the safety and
effectiveness of medications in this population. In response to this unmet need, this proposal will
study the effects of medications in older CKD adults. We will focus on cardiometabolic drugs as such
factors are the most frequent complications of CKD (e.g. cardiovascular diseases [CVD]). Specific
medications were selected for study based on the criteria of high and rising prevalence of use,
potential for fatal harms, concerns for ineffectiveness, and unmet clinical need. We will primarily use
the national Veterans Affairs data, and externally validate findings in a large EHR database. Aim 1 will
evaluate the role of renoprotective therapies (e.g. angiotensin converting enzyme inhibitors; ACEi) in
sustaining long-term kidney function among patients initiating: ACEi vs other antihypertensives (Aim
1a), and sodium-glucose co-transporter-2 inhibitors vs other glucose-lowering therapies (Aim 1b). Aim
2 will elucidate the benefit-risk profiles of newer CVD medications by comparing the incidence of CVD
endpoints and major bleeding in patients initiating: direct acting oral anticoagulants vs warfarin (Aim
2a), and newer antiplatelet drugs (e.g. ticagrelor) vs clopidogrel (Aim 2b). Our central hypotheses are
that (a) due to a confluence of factors (e.g. low prevalence of proteinuria), renoprotective medications
have limited effectiveness in sustaining kidney function; and (b) kidney disease and older age alter
the benefit-risk profiles of medications. The expected impact of this proposal is significant as it will
generate the requisite evidence base to support drug prescribing in this critically understudied
population, impacting 40% of older adults who have CKD. Given the paucity of data from clinical
trials, these findings will serve as the primary source of drug information for patients, caregivers, and
clinicians to make informed decisions. We believe that this proposal outlines the most effective, valid,
and feasible way to generate clinically relevant evidence pertaining to medication effects in older
adults with CKD.

Public health relevance
This proposal leverages high-quality observational data to generate evidence on the effects of medications in older adults with chronic kidney disease (CKD). This research is relevant to public health because >35% of older adults have CKD, and this proposal can help patients, caregivers, and clinicians make informed decisions about their healthcare. Thus, it is in line with the National Institute on Health’s mission to promote safe and effective use of medications.